Examining Sexual Dimorphisms: The Role of Estradiol Signaling in Modulating Immunity

Description (Research Summary for parent award):
Sexual dimorphisms associated with immunity and autoimmunity are well described. In some instances, these
differences have been attributed in part to estradiol or androgen hormone production and signaling; however,
while mechanistic data relating steroids to immune function are emerging, there are still significant gaps in our
knowledge. Our lab has become interested in estrogen effects on the immune system, specifically on innate
immunity, as a result of our work on an unusual disease called lymphangioleiomyomatosis (LAM). LAM is a
rare cystic lung disease found almost exclusively in women. The cystic lung changes are caused by small
multifocal smooth muscle cell clusters in the lungs that contain mutations in one of the two tuberous sclerosis
(TSC) genes. In patients, LAM is highly estrogen sensitive, as it worsens with puberty, pregnancy, and oral
contraception, and stabilizes after menopause. To explain the remarkable female predominance of LAM, as
well as its estrogen sensitivity, we proposed that LAM smooth muscle cells in the lungs may originate from the
myometrium of the uterus. In fact, when we knocked out TSC2 expression in the uterus, all mice developed
aggressive myometrial growth that resembled LAM, with 50% developing lung myometrial nodules from the
uterus later in life. Mouse TSC2-null uteri were highly sensitive to estradiol, as growth was eliminated with
oophorectomy or aromatase inhibitor treatment. In contrast, isolated LAM cells from these mouse uteri, as well
as other TSC2-null cells, had little estradiol sensitivity in-vitro, suggesting that, in-vivo, estradiol promotes LAM
progression indirectly. Preliminary data confirm that in fact estradiol via ERa stimulates innate immunity in
mice by promoting polymorphonuclear (PMN) cell production in the bone marrow. We have further shown that
PMNs stimulate TSC2-null myometrial cell growth in large part through the release of neutrophil elastase (NE).
Here we propose to examine the mechanisms by which estradiol enhances PMN production in the bone
marrow, as well as how estradiol and PMNs act locally within the TSC2-null myometrium to promote LAM
progression. This work will uncover novel mechanisms of estradiol-mediated changes in innate immunity that
will apply to all aspects of biology, from tumor physiology to infectious diseases to autoimmunity.

Public health relevance
Narrative (Research Summary for parent award): Our laboratory is interested in studying how estrogen modules innate immunity to promote the progression of a rare and devastating lung disease found almost exclusively in women called lymphangioleiomyomatosis, or LAM. In human patients and in animal models, estrogen promotes progression of LAM; however, our preliminary data suggest that estrogen is not directly stimulating LAM cells - instead, it is stimulating neutrophil production and activation, which then stimulates LAM progression. Understanding these mechanisms will apply not only to LAM but to many cancers and infectious processes.